A Longitudinal, Measurement Burst Study to Examine the Ecological Validity of the Prototype Willingness Model of Hazardous Adolescent and Young Adult Alcohol Use

PROJECT SUMMARY/ABSTRACT
The proposed research will provide the first daily-level test of the Prototype Willingness Model (PWM),
examining the effects of decision-making cognitions on high-risk alcohol use and related negative
consequences using multi-burst ecological momentary assessment (EMA) across one year among
adolescents and young adults aged 15-25. Based on literature focusing on developmentally appropriate health
models for young adults, the PWM assumes that health-risk behaviors occur either when individuals have
developed intentions to engage in a risk behavior (and these intentions vary as a function of attitudes and
perceived injunctive norms) or through willingness to engage in risks (which varies as a function of perceived
vulnerability to negative consequences, perceived descriptive norms, and prototypes). To improve the
predictive utility of the PWM and to fully understand the relationships between cognitions in predicting high-risk
drinking behavior from a PWM perspective, these associations should be examined close in time at the daily
level (Aim 1), across a variety of risk-conducive situations (e.g., in contexts with presence of peer risk behavior,
marijuana use, unexpected or expected locations, and in contexts with known or unknown people) (Aim 2), and
across different individual characteristics (e.g., age, experience, and personality characteristics) (Aim 3). We
will test these aims by recruiting a community sample of adolescents and young adults (N = 1,100), living in the
greater Seattle metropolitan area, and utilizing multi-burst EMA data collection to assess information about the
daily relations between drinking cognitions and alcohol use across three weekdays and three weekends per
quarter for four quarters across one year. The proposed study is both significant and innovative in that it uses a
lifespan perspective to evaluate the PWM in relation to high-risk drinking behavior both at the daily level and
developmentally over time (i.e., age and experience as moderators), uses multi-burst EMA data collection to
allow for greater insight into factors contributing to increased risk in-the moment to provide guidance to
prevention and intervention work for young adult alcohol use. We will gain a theoretically-informed perspective
to foster prevention and intervention strategies to target those at greatest risk at appropriate stages of the
lifespan and help to determine the timing (e.g., improving young adults' ability to make healthier choices in
moments when they may be at greater risk for engaging in risky behaviors) and type of intervention (e.g.,
focused on social reactance or reasoned pathways) that is most relevant toward individual's needs.

Public health relevance
PROJECT NARRATIVE These data will contribute to the understanding of the etiology of high-risk alcohol use during adolescence and young adulthood by examining the relations between cognitions in predicting drinking behavior from a Prototype Willingness Model perspective. This project will provide new and needed knowledge that will help us to understand these decision-making cognitions and risk behavior at the daily level and how these associations change across development. The proposed application fits within NIAAA's strategic plan and has significant implications for public health as it will help to identify when to intervene in the lifespan (e.g., prior to or after the shift from willingness to intentions) and what mechanisms to target (e.g., willingness, intentions) for adolescent and young adult alcohol use.